Formative work for the development of an intervention to support combined HIV/syphilis self-testing and linkage to prevention and treatment services for transgender women in South Africa

ABSTRACT
In South Africa (SA), the country with the world's largest HIV epidemic, ~45.6% of transgender women (TW) may
be living with HIV. Of these, estimates show that 1/3 are not in treatment. Furthermore, there is low engagement
with HIV prevention behaviors, such as ever having an HIV test (20.5%) and pre-exposure prophylaxis (PrEP)
use (11%). Data on syphilis outcomes, which significantly increase risk for HIV and viral load if already living with
HIV, are unknown in this context; though one estimate of prevalence in SA TW is ~9%. Dual self-testing for HIV
and syphilis may be a promising strategy to improve SA TW's uptake of regular HIV/syphilis testing and linkage
to PrEP and/or HIV/syphilis treatment. Specifically, self-testing is overwhelmingly supported by stakeholders in
SA, the infrastructure to scale-up self-testing is in place and rapidly expanding, analyses show that this strategy
is life and cost-saving in SA, and PrEP and HIV/syphilis treatment are widely available. Also, self-testing may
address the unique social/structural barriers affecting regular testing and subsequent linkage to services for TW,
including transphobia, health system mistrust, discrimination, stigma, cost, and privacy concerns. Thus,
interventions to improve dual self-testing uptake and linkage to PrEP and/or HIV/syphilis treatment following a
self-test are urgently needed for SA TW. Yet, we must first address 3 critical gaps in our knowledge, since
findings from studies on self-testing and linkage in other groups do not extend to TW; formative work shows
TW's life context is unique, and affects self-testing/linkage differently. Gaps include TW's needs/preferences on:
self-test access and uptake; logistical support needed to correctly use/interpret self-tests; and linkage to and
uptake of PrEP and/or HIV/syphilis treatment following self-tests. Using the INSTI Multiplex, a dual blood-based
HIV/syphilis test that delivers results in 1-minute, we use mixed-methods to inform these knowledge gaps and
draft a dual self-testing and linkage to care intervention tailored to TW. Research takes place in Johannesburg,
SA, brings together a gender diverse team and community advisory board (CAB), and is informed by the Mensch
Model; work will occur in 3 stages. In Stage 1, we will conduct in-depth interviews (IDIs) with: N=15 TW and
N=15 healthcare workers (HCW) who care for TW. TW will use INSTI Multiplex in front of a study team member
to provide immediate feedback on logistical support needed to test/interpret results; they will also discuss
preferences on test access, and linkage. In Stage 2, we will enroll N=80 TW to complete self-administered web-
based surveys on their mobile phones. Surveys are developed from IDI themes and will identify TW's preferred
intervention strategy to address each domain. We will engage a data convergence process to ensure that
quantitative/qualitative findings inform one another. We will then draft the intervention using the 4 COM-B
Intervention Function Matrix. In Stage 3 we will engage an intervention development workgroup consisting of at
least n=5 members from each of the following groups: CAB, TW, HCW. We will present them draft intervention
to further develop/refine in 4 meetings of 90-minutes, each. The product will be piloted in a future R34.

Public health relevance
NARRATIVE In South Africa (SA), as many as 45.5% of transgender women (TW) may be living with HIV, and an estimated 1/3 are not in care; estimates of prevention behaviors, such as HIV testing, and pre-exposure prophylaxis (PrEP) use are also low (20.5% and 11%, respectively) and prevalence of syphilis, which drastically increases HIV risk and viral load, is ~9%. This study uses the Mensch Model to fill 3 critical information domains necessary to develop a dual HIV/syphilis (via INSTI Multiplex) self-testing and linkage-to-care intervention for SA TW, including needs/preferences on: self-test access/uptake, logistical support to use/interpret tests, and linkage to and uptake of PrEP and/or HIV/syphilis treatment. In 3 stages, we will: 1) conduct in-depth interviews (IDIs) with SA TW (N=15), and healthcare workers who care for SA TW (HCW; N=15) to understand preferences on the domains (Stage 1); send web-based surveys to SA TW's mobile phones (N=80), to identify the most popular strategies address each domain, and converge qualitative and quantitative data to draft the intervention using the 4 COM-B Intervention Function Matrix (Stage 2); and 3) convene an intervention development workgroup consisting of at least n=5 members from each our CAB, TW, and HCW groups (total of at least N=15 workgroup group participants) to further develop/refine the intervention to be pilot tested in a future R34 (Stage 3).